Wearable multifunctional optical device for early detection of postpartum hemorrhage

PROJECT SUMMARY (See instructions):
Postpartum hemorrhage (PPH), defined as the loss of 1 L of blood or more within 24 hours after birth, is the
leading cause of maternal mortality worldwide. Importantly, PPH is the most preventable cause of maternal
mortality, and the leading factors causing preventable PPH are delays in diagnosis and treatment. Thus,
there is an urgent need for an early and accurate alert system that can facilitate prompt treatment to
prevent PPH-related morbidity and mortality. During hemorrhage, the body tries to compensate for blood
loss by shunting blood from the periphery to vital organs and replenishing reduced blood volume with water
from the interstitium. These compensation mechanisms help stabilize the patient, delaying the time until
global vascular indicators such as blood pressure and heart rate are affected, the current measurements
used to predict PPH. Thus, monitoring of peripheral blood flow and blood content can yield early indicators
of hemorrhage. Optical technologies are well suited to noninvasively measure blood flow and blood
content. Preliminary experiments demonstrated sensitivity to reduced perfusion in vivo and measured
significant differences between blood samples diluted to physiologic levels seen during PPH using
complimentary optical approaches. We hypothesize that early changes in peripheral blood flow and water
transfer from interstitium to the vasculature will be detected using wearable optical techniques, and such
changes can signal early stages of PPH. We will develop a multifunctional wearable optical device and test
it in pregnant patients at high and low risk of PPH. These studies will create a database of PPH signatures
that will help inform diagnostic algorithms that will provide an early warning system for improved PPH
management.

Public health relevance
RELEVANCE (See instructions): Postpartum hemorrhage, the loss of one liter of blood or more within 24 hours after birth, is the leading cause of maternal death despite being largely preventable with early diagnosis and treatment. Although not currently monitored, immediate physiologic changes help stabilize the patient and likely provide a window of opportunity for treatment at early stages of hemorrhage when simple treatments are most effective. The goal of this proposal is to develop a new wearable light-based device that accurately detects these compensatory changes associated with postpartum hemorrhage, thereby facilitating improved maternal health outcomes with early treatment.